Carolina Center on Population Aging and Health: Administrative Core

ABSTRACT Core A
The Administrative and Research Support Core of the Carolina Center for Population Aging and
Health (CCPAH) has the overarching goals of fostering creative research and high-quality data
collection, reducing the administrative and technical burdens on faculty of conducting that
research, and managing the Center's activities so that the goals of the CCPAH are realized.
This core will organize seminars and workshops related to the Center's themes, identify faculty
new to UNC or whose work logically relates to our themes, streamline administrative processes
so that faculty can focus on science, and manage the day to day operations of the center.
The success of this Core, in combination with the success of the Center overall, will result in
several outcomes. Most importantly, data collection projects undertaken by CCPAH faculty will
better reflect the state of the art with respect to aging-related design and content and will be
better integrated with one another and with other surveys that are major resources for aging.
This outcome is central to our ambition of enhancing research on aging at CCPAH and
elsewhere because the projects will place major new data sets in the public domain, which will
be more useful to scholars of aging both within CCPAH and worldwide if their design
incorporates cutting-edge approaches and supports comparisons to other data. The Core will
leverage existing structures at the Carolina Population Center, CCPAH's administrative home,
that work well, but also develop new activities to make sure that CCPAH accomplishes the work
it has proposed over the coming five years. The combination of the CCPAH PI, Core Leaders,
project manager, and CPC's experienced professional staff on which CCPAH will draw, all of
whom are deeply committed to the goals we have developed, will provide strong leadership for
CCPAH in the coming years.